Video Inspired Discussions about Ethical Outcomes in Pediatrics (VIDEO-PEDS)

Parents of children with cancer often face complicated decision making throughout their child’s illness.
Goals-of-care (GOC) interventions help patients, their families, and clinicians communicate and discuss
preferences for treatments together to ensure medical care is consistent with the family’s values, goals, and
informed preferences. To date, most GOC interventions have focused on adults and adolescents
resulting in a critical disparity of available tools for children dying of cancer. GOC conversations
between parents, who serve as primary decision makers for children, and clinicians often rely on verbal or
written information about possible medical interventions, such as cardiopulmonary resuscitation or placement
on a respirator, during crises of clinical decline. However, this GOC process is often inadequate as it is
presently conducted, leaving families ill-prepared in times of distress.
The majority of children with cancer and their families prefer to die at home, yet the majority of children with
cancer die in the hospital, and this disproportionately affects African American, Hispanic, and rural patients.
Novel interventions are needed to ensure GOC conversations happen earlier to ensure goal-concordant care.
To address these shortcomings, we have developed theory-based GOC video decision aids in English and
Spanish for parents of children with cancer. We have shown the efficacy of similar decision aids in adults using
Natural Language Processing (NLP), a form of computer-assisted abstraction, in pragmatic trials; but have not
examined the impact of these videos in children with cancer and their parents.
The overall objective of this UG3/UH3 proposal entitled Video Inspired Discussions for Ethical
Outcomes in Pediatrics (VIDEO-PEDS) is to build the infrastructure for and conduct a large randomized
pragmatic trial of a GOC video decision aid in three diverse health care systems (Dana-Farber Cancer
Institute, Children’s Healthcare of Atlanta, and the University of Alabama). During the UG3 Phase (first two
years), we will refine the GOC video, finalize clinics and workflows, validate our NLP process, and pilot-test the
intervention. During the UH3 Phase (subsequent four years), we will conduct a large, pragmatic, randomized,
waitlist-controlled trial including 504 children with cancer aged 0-12 years. This trial will include 76 African
American, 76 Hispanic, and 76 rural children with cancer by design. Children will be randomized to Waitlist-
Control or the GOC Video Intervention in which the video will be shared with parents along with in-person and
telehealth sessions conducted by navigators to elucidate GOC preferences. After the intervention period, the
waitlist will open and all parents (i.e., Waitlist-Controls) will receive the intervention. Using NLP to detect
outcomes (e.g., GOC documentation), we hypothesize that intervention children, as compared to controls, will
have more GOC documentation (primary outcome). This proposal is significant, innovative, and feasible. The
intervention is a practical and innovative approach to help children with cancer and their parents.

Public health relevance
It is imperative to develop effective serious illness care approaches to support children with cancer and their parents. By providing video education tools to better inform parents making decisions about life-prolonging interventions, there is an opportunity to improve their children’s quality of life throughout the care trajectory.